The Sigma factor SigE's role in mycobacterial granulomas

Abstract: Infections caused by Mycobacterium tuberculosis (Mtb) have historically been the leading cause of
death from a single infectious agent and still result in 1.5 million deaths annually. One of the hallmark
characteristics of the disease is an aggregate of immune cells called the granuloma, where macrophages
develop epithelioid character, expressing epithelial cadherin (E-cadherin) and other canonical markers of
epithelial cells. This structure restrains the bacteria within but is unable to eradicate the infection despite exposing
the pathogen to pH changes, hypoxia, and antimicrobial peptides. The unique, lipid-rich cell envelope of
mycobacteria protects them from these stressors while simultaneously modulating the host immune response.
Thus, targeting bacterial cell envelope components that are specific to the granuloma is a potential avenue for
future drugs and therapeutics. Using the zebrafish-Mycobacterium marinum (Mm) model to recapitulate key
aspects of TB disease, the proposed aims will uncover novel bacterial elements with importance in mycobacterial
granulomas. I will explore how specific cell envelope components impact both mycobacterial survival and host
dynamics in mycobacterial granulomas. I will assess how the bacteria sigma factor SigE (σE) impacts survival
within the granuloma through cell envelope-mediated interactions with the host immune response. We have
identified SigE as a potential modulator of bacterial survival in the granuloma, which will help better understand
the host-pathogen interactions that occur in the granuloma. In addition, the knowledge of bacterial factors that
allow mycobacterial persistence in granulomas can unveil potential drug targets and therapies to treat
tuberculosis.

Public health relevance
Tuberculosis granulomas are have been studied for over 150 years, the bacterial factors involved in this immune structure are relatively understudied. Using the zebrafish- Mycobacteirum marinum model to recapitulate this important aspect of tuberculosis disease, this proposed research will elucidate how a bacterial factor, SigE, is important for both bacterial survival and modulation of host immunity in mycobacterial granulomas. Identifying and determining the bacterial factors that allow mycobacteria to persist in the granuloma can unveil potential drug targets and therapies to treat tuberculosis infection.